Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core of the Mayo Clinic Alzheimer's Disease Research Center (ADRC) provides
oversight for the operation of the ADRC in both geographic locations, Mayo Clinic Rochester (MCR) and Mayo
Clinic Florida (MCF). The Core will be the liaison between the ADRC and the National Institute on Aging and
between the ADRC and the Mayo Clinic. The primary focus of the ADRC will be to promote research on
Alzheimer's disease (AD) and Alzheimer's disease related disorders (ADRD) to address the theme of the
Center, “Similarities and Differences Among Neurodegenerative Diseases.” The Administrative Core will
provide support for financial, personnel and data and specimen sharing operations and will coordinate activities
among the seven cores of the ADRC: Administrative, Clinical, Neuropathology, Data Management and
Statistical, Outreach, Recruitment and Engagement, Neuroimaging and Biomarker Cores and the Research
Education Component. The Developmental Projects Program will be managed by the Core, with the goal of
engaging young investigators. An External Advisory Committee will be convened annually and will meet at
either location. The Core will also promote diversity issues regarding participants, faculty and trainees.
Compliance with human subjects' protection will be monitored by the Core, and appropriate staff education will
be implemented.